BABY DEVELOPMENTAL FOLLOW-UP NETWORK PROJECT IN COLORADO

This is a collaborative project of Physical and Occupational Therapists throughout the State of Colorado which will establish a statewide network for developmental follow-op of low birth weight infants.